Translation regulation of the mesenchymal transition by the rRNA and mRNA m6A axis

PROJECT SUMMARY
Currently there are no effective treatments that can cure metastatic breast cancer. The epithelial-to-
mesenchymal transition (EMT) is a critical cancer cell plasticity and dedifferentiation program by which epithelial
cells acquire pro-migratory and invasive mesenchymal properties. To initiate the EMT program, cancer cells
need to receive pro-EMT signals, such as TGF from either neighboring tumor cells or from the
microenvironment (surrounding stroma).
Our research group made the unexpected finding that during TGFβ mediated EMT, Pol I rDNA transcription
is: (1) driven by Snail, a transcription factor known to play a central role in orchestrating the mesenchymal Pol II
dependent gene expression program required for cellular invasiveness and metastatic spread; (2) a concurrent
loss of Myc occurs at rDNA genes; and (3) Snail forms a complex with METTL5 to enable that the newly made
rRNA are m6A modified by METTL5 before the rRNA is incorporated into the mature ribosome; (4) Snail also
forms a complex with METTL3 and may therefore direct m6A modifications of selective mRNAs; (5) the m6A
marked mRNAs enables recruitment of the non-canonical DAP5/eIF3d/METTL3 translation complex to drive
selective m6A marked mRNA translation in the mesenchymal state; and (6) METTL5 is required for execution of
the EMT program, as silencing of METTL5 prevents cells from undergoing EMT.
The focus of this grant application is to gain a deeper molecular understanding of Pol I rDNA
transcription, METTL5 m6A modified rRNA and ribosomes and why selective DAP5/eIF3d mediated
translational control is essential for orchestrating breast cancer cell plasticity in EMT, its role in breast
cancer metastatic progression, and how Snail orchestrates and coordinates the m6A rRNA/mRNA axis.
This knowledge will ultimately inform how targeting Pol I machinery, specialized ribosomes and translation
control could represent a novel therapy specifically targeting the plastic, non-proliferating and chemo-resistant
EMT cells fueling tumor reoccurrence and metastasis.

Public health relevance
PROJECT NARRATIVE Epithelial-to-Mesenchymal Transition (EMT) is a cancer cell plasticity program linked to metastasis. Based on our novel data this proposal will explore the hypothesis that EMT requires the generation of specific modified ribosomes that translate EMT-driven mRNAs that fuels metastasis. We propose that EMT-specific ribosomes are manufactured by (i) activation of ribosome genes by a Pol I-Snail transcriptional complex and (ii) Snail promotes binding of METTL5 on de novo synthesized rRNA enabling rRNA specific m6A modifications before its incorporation into the ribosome. By forming a complex with METTL3 Snail also directs m6A modifications of selective mRNA enabling recruitment of the non-canonical DAP5/eIF3d/METTL3 translation complex to drive selective m6A marked mRNA translation in the mesenchymal state.